Cells and Tissue Core-Core 5

Project Summary/Abstract (Cells and Tissue Core - Core 5)
The Cells and Tissue Core was established to provide well-differentiated epithelial models for studies on the
pathophysiology of cystic fibrosis (CF) and for molecular and gene therapy experiments. The Cells and Tissue
Core mission is to advance CF research within the scope of the National Institute of Diabetes and Digestive and
Kidney Diseases. CF affects multiple organs that result in digestive diseases, liver diseases, nutritional disorders,
diabetes, and lung disease. These disorders affect people's health and quality of life. The Core achieves this
mission by providing relevant models and technical expertise to investigators, developing new in vitro models and
approaches, training investigators, and attracting new investigators to CF research and aiding their development.
The goals of the Cells and Tissue Core are to collect, process and maintain a human tissue biobank of
gallbladder, intestine, pancreas, vas deferens, kidney, and lung specimens, in collaboration with the Clinical
Core (Core-6). We will also generate in vitro models of these same organs from humans, pigs, ferrets, and
mice with and without CF. The Core will also characterize models and native epithelia in collaboration with
other Cores and investigators and perform bioelectric analyses, morphological evaluation, gene expression
profiles, and pH measurements in surface and luminal liquid. Finally, the Core will teach investigators at the
University of Iowa and other institutions how to successfully implement the methods for in vitro model systems.